Stress and Affective Mechanisms that Relate to Inflammation in Diverse Older Men and Women

Project Summary/Abstract
Prolonged, elevated inflammation is detrimental to health, with ties to disease and mortality, making prolonged,
elevated inflammation an economic burden and public health issue. Daily stressors and affective reactions to
daily stressors may be mechanisms that increase risk for prolonged inflammation and downstream health
outcomes. Possible pathways through which daily stressors are linked to inflammation remain poorly
understood, particularly in older adulthood– when risk for prolonged inflammation is already elevated. Although
research identifies daily stress processes (i.e., exposure, severity, affective reactions) as important factors by
which stress can affect health, few studies examine how these aspects of daily stress inform inflammation.
Those that have examined such associations have focused on middle-aged adults and two indicators of
inflammation (C-reactive protein [CRP], interleukin-6 [IL-6]). Recent research also identifies daily stress
processes as modifiable targets for addressing gender disparities in health outcomes. The goal of this research
is to identify which aspects of daily stress processes – frequency, severity, and affective reactions to daily
stressors – are linked with heightened inflammatory biomarkers in older adults, and the extent to which these
associations vary between men and women. The proposed research will use data from a recent wave of the
Einstein Aging Study (EAS; N=289). A racially diverse sample of older adults (70+ years) participated in a 14-
day ecological momentary assessment (EMA) study, with two blood draws pre- and post- EMA period. In
addition to eight pro- and anti-inflammatory biomarkers assayed for both basal and stimulated cytokines, the
current proposed research will assay one additional cytokine (macrophage migration inhibitory factor [MIF]),
theorized to be highly related to psychosocial stress. Aim one will identify how the frequency and severity of
daily stressors relate to inflammatory biomarkers. Aim two will determine how both initial (same-day) and
prolonged (next-day) affective reactions relate to associations between frequency and severity of daily
stressors and inflammatory biomarkers. Aim three will examine gender/sex as a moderator of the associations
tested in aims one and two. Current interventions for managing or decreasing prolonged inflammation suggest
viable pathways such as medication, or changes in diet and exercise, but not stressors. Findings from this
study will provide critical information on what aspects of daily stress processes may be utilized as modifiable
psychosocial intervention targets for managing and decreasing prolonged inflammation, and for whom these
interventions should be different. In addition, understanding how prolonged affective reactions are linked to
inflammation can inform how researchers design intensive repeated measurement studies. The proposed
hypotheses will be tested with multilevel structural equation modeling. Dr. Witzel and co-investigators, Drs.
Jennifer Graham-Engeland and Christopher Engeland, are uniquely positioned to carry out the proposed
research given their joint expertise in daily stress processes, affect, and inflammation among older adults.

Public health relevance
Project Narrative Older adults – particularly older women – are at increased risk of prolonged inflammation and inflammatory- related diseases; one way through which older adults may be at higher risk for prolonged inflammation and inflammatory disease is through daily stress processes. The proposed research will examine how aspects of daily stressors (i.e., frequency, severity, immediate and prolonged affective reactions to daily stressors) are linked with inflammatory biomarkers in a racially and socioeconomically diverse sample of older adults, and how gender may differentially inform these associations. Study findings will determine the contexts in which intervention efforts may be particularly advantageous and may inform future studies using complex, repeated methodology.